Frederick Animal Health Vet-LIRN Network Capacity Building Project

Abstract: The focus of this proposal is to seek funding for the Frederick Animal Health Laboratory (FAHL) to expand the capability to support the mission of Vet-LIRN (Veterinary Laboratory Investigation and Response Network), though the addition of a Pathology Grossing Station in Necropsy, a Biological Safety cabinet in Microbiology, and a centrifuge for sample processing. FAHL is an ISO 17025 Accredited diagnostic laboratory and is part of the Maryland Department of Agriculture. FAHL has the staff, equipment, technology, and management system to be able to provide critical resources that will benefit and support Vet-LIRN.

Public health relevance
Project Narrative: Recent years have seen an increase in the threats to the food safety and security of both human and animal food supplies. In the proposed cooperative agreement Frederick Animal Health Laboratory will partner with the Veterinary Laboratory Investigation and Response Network (Vet- LIRN) to provide increased resources for the investigation of and response to animal food related illnesses through the addition of a though the addition of a Portable Grossing Station in Necropsy, a Biological Safety cabinet in Bacteriology, and a centrifuge for sample processing. The portable grossing station will add histologic preparation capability to the lab that will directly enhance the service that is offered for Vet-LIRN cases, as this would be a new service offering from FAHL. The Biological Safety Cabinet would double the analysis capacity of the microbiology section in response to Vet-LIRN case investigation from both internal Necropsy and direct sample submissions. The centrifuge would be used for increasing sample processing capacity of microbiology and PCR testing that is included in Vet-LIRN case investigations while providing increased biosecurity for scientists.